Novel role of Foxc2 in regulating metabolic disease

Abstract
The long-term goal of this proposal is developed to uncover the molecular mechanisms and identify
critical regulators governing lymphatic vascular function in health and disease in hopes of offering
potential new therapeutic targets to combat cardiovascular and metabolic disorders. At the third year
of postdoctoral training, the PI has published his first postdoctoral project and presented his studies in
several prestigious conferences that pave the way for his transition to an independent investigator.
The lymphatic system is responsible for maintaining interstitial fluid homeostasis, immune cell
trafficking and lipid absorption. Lymphatic function participates largely in the pathogenesis of metabolic
and cardiovascular diseases such as obesity and atherosclerosis. How lymphatic dysfunction leads to
abnormal lipid transport and fat deposition, and conversely, how these metabolic diseases impair
lymphatic function are poorly understood but highly medically relevant questions. Embryonic mice
lacking Foxc2, a key transcription factor, prevents the formation and maturation of collecting lymphatic
vessels. Despite the crucial role of Foxc2 in lymphatic development and remodeling, little is known
about the role of Foxc2 in adult physiological and pathological lymphatic function; limitation is largely
due to a lack of appropriate animal models. In this proposed application, the PI recently has generated
novel inducible lymphatic endothelial cell (LEC)-specific Foxc2 gain-of-function and Foxc2 loss-of-
function mice. Utilizing these powerful genetic tools, the PI observed that deficiency of LEC Foxc2 in
adult mice dramatically increased the lymphangiogensis, improves impaired lymphatic drainage and
lipid absorption in metabolic disorders (unpublished data). In the K99 phase, the PI will continue the
current project to determine the molecular mechanism by which Foxc2 regulates adult
lymphangiogenesis and lymphatic function in obese model. While in R00 phase, the PI will investigate
the role of Foxc2 in modulating macrophage cholesterol efflux and reverse cholesterol transport in
atherosclerotic model, as well as how Foxc2 will affect atherogenesis, which is diverging from his
mentor’s work on Epsin, a family of endocytic adaptor proteins. Moreover, other than the unique mouse
models and cutting-edge techniques, the PI will develop a novel LEC-specific nanoparticle delivery
system based on his recent published platform to specifically target LEC Foxc2, thus may halt
inflammation and inhibit atheroma progression. This proposal will be valuable for restoring impaired
lymphatics to treat cardiovascular and metabolic diseases.

Public health relevance
Project narrative Lymphatic dysfunctions are associated with many cardiovascular and metabolic diseases such as obesity, atherosclerosis, lymphedema, and immune suppression, which have limited or no clinical approaches to treat. Restoring impaired lymphatic vessels and maintaining a proper lymphatic drainage plays a crucial role in lipid metabolism and cholesterol transport. The proposed studies in this project are significant as a better understanding of these processes may enable the development of novel therapeutic treatment for cardiovascular and metabolic diseases.